Uncovering Dementia-Related Lipid Alterations and Mechanisms in Astrocytes

PROJECT SUMMARY
Alzheimer’s disease (AD) and related dementias (ADRD) are multifactorial disorders with complex pathological
mechanisms. Proteinopathy, neuronal impairments, and neuroinflammation are well-known hallmarks of ADRD.
Lipid dysregulation is also a prominent feature of AD pathology. Genes that control lipid metabolism are
implicated in AD, and plasma and brain lipid levels are altered in disease. Therapeutically modifying lipids might
alleviate behavioral and cognitive decline and risk of neurodegenerative disease, but additional studies are
needed to better understand lipid-related molecular changes and their effects on brain function and disease.
Astrocytes are essential for brain lipid homeostasis due to astrocytic enrichment of lipid-related factors and the
dependence of neurons on astrocytes for lipid turnover and various lipid-based processes. However, the effects
of dementia-associated pathological factors and disease cascades on astrocytic lipids have not been defined.
Moreover, how changes in astrocyte lipids are regulated and how they influence forebrain neurons is unclear.
Further investigations are required to define astrocytic lipid signatures and lipid-based alterations and how they
influence neuronal function and vulnerability to disease.
Our preliminary data suggest that proteinopathy and neuroimmune factors influence astrocyte lipid
synthesis and release, which may affect astrocytic-neuronal interactions and neuronal health in aging and
disease. Based on our novel results, we hypothesize that AD-related proteinopathy and neuroimmune signaling
induce maladaptive changes in astrocytic lipid metabolism and release that promote neuronal vulnerability in
dementia. In the proposed R21 study, we will use lipidomics and other advanced approaches in mouse models
to characterize the spatiotemporal alterations in astrocyte lipids during aging and disease (Aim 1) and investigate
how alterations in astrocytic lipids are regulated and may promote neuronal impairments and vulnerability to
disease (Aim 2). We will perform innovative lipidomic profiling in astrocytes at different ages and across brain
regions, which will address previously underappreciated molecular signatures in astrocytes. We will also use a
novel approach of spatial lipidomics to resolve lipid-based changes across brain regions and use isolated mouse
astrocytes and human iPSC-derived astrocytes to identify cell-autonomous effects and molecular mechanisms
that regulate astrocyte lipids and lipid-based astrocytic-neuronal interactions. In summary, the proposed study
seeks to elucidate novel lipid signatures and molecular mechanisms associated with ADRD, which may reveal
new therapeutic strategies for neurodegenerative disorders.

Public health relevance
PROJECT NARRATIVE Dementia involves changes in brain lipids, but the exact cell type-specific effects and mechanisms are not clear. Astrocytes are essential for brain lipid metabolism and neuronal function, and may be impaired in dementia. The proposed study will investigate how dementia-related factors and pathways influence astrocyte lipids and lipid- based regulation of neuronal function.